Role of small molecule interactions and multiprotein assemblies in CYP1B1 disease-associated function and dysfunction

Abstract The goal of this project is to determine how mutations, elevated protein levels, and environmental conditions impact the function and dysfunction of Cytochrome P450 1B1 (CYP1B1). The addition of instrumentation is proposed to facilitate characterization of small molecule modulators of CYP1B1, and the metabolic products of this CYP. Selective inhibition of CYPs is an important goal in medicinal chemistry, but these enzymes can chemically modify their inhibitors, resulting in deactivation. The requested High Pressure Liquid Chromatography (HPLC) instrument, along with three orthogonal detection systems, will allow for accurate and rapid determination of chemical structures and enzymatic modifications. This will be accomplished with small amounts of sample, as the analytes will come from cells grown in tissue culture. As CYPs generally increase the polarity of hydrophobic substrates, the instrumentation includes specific modifications that are required for analysis of aqueous media solutions. Such solutions are incompatible with most LC mass spectrometers. This equipment will be also used to evaluate if mutations, protein:protein association, and environmental conditions alter CYP metabolic products, with implications for tissue-selective metabolism under hypoxia or due to the presence of signaling molecules.

Public health relevance
Cytochrome P450-1B1 (CYP1B1) is absent or expressed at very low levels in the liver and healthy tissues while being overexpressed in tumors, giving it the title of “universal tumor antigen”. Evidence from basic science, clinical, and epidemiological studies demonstrate that CYP1B1 is involved in cancer initiation, progression, and resistance to a wide range of chemotherapeutics. This work will define how CYP1B1 subcellular localization, oligomerization, degradation, and small molecule binding are altered in cancer cells as a function of specific single nucleotide polymorphisms (SNPs) and environmental factors, facilitating malignant progression, and will provide a new paradigm for small molecule inhibitors of the enzyme that function by inducing CYP1B1 protein degradation.